Wellness Achieved Through Changing Habits (WATCH): An Acceptance-Based Healthy Lifestyle Intervention for Diverse Adolescents

ABSTRACT
Overweight/obesity (OW/OB) affects 14 million adolescents in the United States, disproportionately affecting
girls and racial/ethnic minorities, increasing their risk of cardiovascular disease and type 2 diabetes. Behavioral
weight loss interventions are the foundation of obesity treatment modalities, yet many have led to limited
weight loss and weight regain is common. Limited success in adolescent weight loss interventions may be
attributed primarily to adolescents’ lack of self-regulation skills, which are essential for adhering to diet and
physical activity goals. There is a critical need for development of interventions that teach self-regulation skills
to adolescents in order to adapt to pervasive biological and environmental cues that are often experienced
during weight loss. An innovative behavioral treatment, acceptance-based therapy (ABT), focuses on self-
regulation skills and increasing mindfulness and tolerance of negative or uncomfortable emotions. ABT has
demonstrated strong evidence as an effective weight loss strategy in adults. Our group utilized an adolescent-
engaged approach to develop, implement, and test the feasibility and acceptability of an ABT weight loss
intervention for adolescent girls with OW/OB. The feasibility study was a 6-month ABT behavioral weight loss
intervention comprised of 15 in-person group sessions (90-minutes each) over a 6-month period led by an
instructor trained in ABT. The feasibility study demonstrated strong acceptability among adolescent girls with
OW/OB. The objective of this study, called the Wellness Achieved Through Changing Habits (WATCH) trial, is
to test the efficacy of an ABT intervention versus an enhanced care (EC) intervention on markers of
cardiometabolic health, health related behaviors, and psychological factors. During the R61 phase (year one),
we will finalize all WATCH policies and procedures including clinical trials registration, manual of operations,
IRB approvals, convening the DSMB board, and begin recruitment. We will also submit a NIH progress report
on participant recruitment, demographics, and intervention fidelity. During the R33 phase (years 2-5), we
propose a randomized controlled trial of 148 adolescent girls (≥40% racial/ethnic minorities) with OW/OB to
test the hypothesis that those randomized to ABT (vs. EC) will have significantly decreased BMI z-score
(primary outcome) and body fat, and improved blood pressure and blood lipids at post-treatment, 6-month
follow-up, and 12-month follow-up. We also hypothesize that relative to EC intervention, ABT will significantly
improve health-related behaviors and psychological factors. As an exploratory aim, we will examine the extent
to which ABT’s effects on weight and body composition are mediated by improvements in behavioral and
psychological factors, and identify key moderators of ABT intervention effects including baseline demographic
and psychological factors. This study will yield a novel, obesity intervention tailored to the needs of adolescents
with OW/OB by developing self-regulation skills and providing tools to promote cardiometabolic health.

Public health relevance
PROJECT NARRATIVE Standard care for obesity produces minimal weight loss and weight regain is common. An innovative behavioral treatment, acceptance-based therapy (ABT), focuses on self-regulation skills and increasing mindfulness and tolerance of negative or uncomfortable emotions and is highly effective for weight loss in adults. Our study team has developed and tested an ABT weight loss intervention for adolescent girls and the objective of this proposal is to randomize adolescent girls with OW/OB to an ABT versus an Enhanced Care (EC) intervention to test the efficacy of an ABT intervention on physiological, behavioral, and psychological factors related to cardiometabolic health.